STATISTICAL ANALYSES FOR GENETIC EPIDEMIOLOGICAL STUDIES

Gene mapping studies using DNA markers to detect craniofacial and oral diseases utilize a wide variety of statistical techniques. We are developing a scheme to better integrate these software tools. Since many of these programs were written elsewhere using a variety of computer languages and input formats, integrating them with our internal database will streamline the analysis process. We are constantly updating our suite of statistical analysis tools as the field of genetic epidemiology is under very rapid development, with improved methods and computer programs regularly being made available. Part of our work also involves investigation of basic statistical studies such as an investigation of specific aspects of the software procedure SAS PROC MIXED, with the objective of better understanding proper application to dental data. Collaborations with colleagues at the NIAAA and Queensland Institute of Medical Research have provided us with access to unpublished software programs for genetic analyses. We have recently made available portions of our statistical analysis software to colleagues at the NHGRI and are providing training for their staff in the use of these programs.